Cancer Metabolism & Microenvironment

The overall goal of the Cancer Metabolism & Microenvironment (CMM) Program (formerly Cell and Molecular Biology of Cancer Program) is to generate new knowledge about potential targets for cancer therapy and to translate this information into more selective and efficacious treatments.

Public health relevance
N/A